Beyond Reserve: Dynamic Neurocognitive Adaptation

Our proposed project focuses on understanding the concepts of reserve and resilience, switching from a static
perspective often applied in the literature to dynamic adaptation to the environment. Our validated dynamic
Neurocognitive Adaptation (dNA) Scale will explore how individuals are engaged in protective cognitive and
leisure activities, throughout their lifetime, and the relationship between these behaviors and gold-standard
neuropsychological-neurophysiological markers of cognitive health, to understand presentation and
mechanisms of individual adaptation to the environment through life. Neuropsychological measures of working
memory and executive functions will be used to assess cognitive flexibility, while graph theoretical metrics of
functional connectivity (FC) will be used to assess neurophysiological efficiency. Together, these components
will give us a measure of neurocognitive adaptation, which is likely to clarify mechanisms of AD resilience. We
will further investigate the role of AD risk factors and early pathology (amyloid, inflammation) in moderating
effects of adaptive behavior on outcomes. Furthermore, as women show different structural and functional
reserve characteristics, we will include sex as a factor when examining individual dynamic adaptation to the
environment. The objective of this proposal is to investigate multiple domains (cognitive, physical, creative, and
social) in 7-time windows from childhood (0-10 years old) to old age (+ 65 years old), exploring individual
adaptation to the environment and its potential protective factors against neurodegeneration. Testing
convergent validity of the dNA against gold-standard neuropsychological tests and fMRI measures of executive
function in aging is an important innovation, and lays a foundation for implementing the dNA in at-risk and AD
populations. The rationale for this project is that the concept of reserve is mostly static, based on unmodifiable
variables (IQ and formal education), and poorly suited for understanding the role of time in this protective role.
From our perspective, environment and learning change through the lifetime dynamically, as does individual
subjective adaptation to environment. Specific Aim 1 will determine association of adaptation profiles with
education and gold standard measures of cognitive flexibility, such as working memory, problem solving, setshifting,
and inhibition in cognitively Healthy Controls (HCs). Our hypothesis is that greater maintenance in
activities through lifetime will relate to higher education and better cognitive flexibility and peripheral
inflammation will moderate this effect. Specific Aim 2 will establish association of adaptation profiles and gold
standard measures of neurophysiological efficiency through fMRI (FC) and graph theoretical metrics during
resting state. Our hypothesis is that greater maintenance in activities through lifetime will relate to better
segregation of the Default Network (DN) and parahippocampal–hippocampal network, and integration with
other regions, with stronger anticorrelation between DN activation – Dorsal Attention Network (DAN)
deactivation during resting state. Peripheral inflammation will moderate this effect. Specific Aim 3 will explore
the specific role of the dNA as a moderator between sex and the “neurocognitive efficiency” in HCs and Mild
Cognitive Impairment (MCI). Our hypothesis is that in HC and MCI patients the association between risk
factors (predictors) and neuroefficiency (outcomes) will be moderated by the dNA profile. To achieve these
aims, we will recruit participants from Cleveland Clinic Lou Ruvo Center for Brain Health.